Promoting Health Aging through Semantic Enrichment of Solitude Research (PHASES)

Research on solitude often highlights the risks of spending time alone with a focus on negative outcomes, such
as mortality and depression. When positive outcomes are associated with solitude, such as increased
calmness and lower rates of depression, they are often found most strongly among midlife and older adults.
Research on gerotranscendence, which focuses on a sense of psychological connectedness beyond oneself in
aging, emphasizes healthy aging and positive outcomes such as enhanced psychological well-being. These
areas of research have clear overlap in the context of midlife and older adulthood, but there is at present a gap
between the respective literatures. This is partially because even within each ﬁeld, constructs related to
solitude or gerotranscendence are described ambiguously, making it challenging to discern when researchers
are in fact using the same construct across studies. Additionally, explaining overlap among constructs in these
literatures is non-trivial, requiring evaluation of a range of factors from personal choices to health-related
factors to external circumstances. Yet by integrating these areas of study, we will deepen our understanding of
the role of solitude in promoting healthy aging and inspire innovative research directions.
Our project, titled "Promoting Health Aging through Semantic Enrichment of Solitude Research
(PHASES)," aims to bridge the gap between these literatures and thus spur novel research into healthy aging.
In pursuit of that aim, we will develop the Solitude Ontology and the Gerotranscendence Ontology, each
extending from the upper-level Behavior Change Intervention Ontology. It is of course not enough to simply
create ontologies representing core content in these literatures. To make this knowledge useful to
stakeholders, we will create a web portal to provide automated literature recommendations and an interface for
posing natural language questions about articles in and across these respective literatures. We intend this
platform to serve as a hub for researchers, educators, and other professionals to explore and delve into these
interconnected concepts, in the interest of identifying, developing, and reﬁning interventions for promoting
healthy aging. It is of course not enough to simply create ontologies and an interface to access them. We will,
accordingly, pursue an extensive dissemination campaign, involving conference and workshop presentations,
consensus-building exercises with other subject-matter experts, peer-reviewed publication, as well as graduate
and undergraduate training in the uses of our ontologies and the portal.
Our multidisciplinary team is uniquely positioned to complete this project, with experts in solitude,
gerotranscendence, ontology engineering, and semantic web technologies. PHASES is a mission to foster
new, groundbreaking research by merging historically separate yet interconnected ﬁelds. Through this
synthesis, we aim to enhance our collective understanding of how solitude can be a positive force, contributing
to ﬂourishing and well-being in mid- and old age.

Public health relevance
Research on solitude and gerotranscendence is siloed, despite significant overlap in the context of older adults. Ambiguous constructs within each field make integration challenging, but also motivate our project "Promoting Health Aging through Semantic Enrichment of Solitude Research (PHASES)" which seeks to integrate these fields by developing ontologies and a web portal to foster innovative research on healthy aging.